Administrative Core

Core of the Antiviral Drug Discovery and Development Center (ADSC) will provide a key role in leadership, communication, coordination and oversight ofthe projects and cores, and stimulate collaboration and synergy between the projects. Operationally, it is in charge of fiscal and contractual management of the center and will plan and implement activities, such as meetings of the Executive Committee (EC), External Scientific Advisory Board (EAB), and an annual meeting of all projects and cores. In addition, it will manage the inter-institutional cooperative agreements. The core is also responsible for managing the solicitation and review of Supplemental Research Projects applications, such as those for additional product development and support for IND-enabling studies. Finally, the core will facilitate dissemination of progress and discoveries to the public.

Public health relevance
The Administrative Core will provide information and assistance to Antiviral Drug Discovery and Development Center project investigators who are developing potential therapies for emerging infections such as West Nile virus and influenza. The Core will also assist with preparing reports and publications that will allow public access to data and results that are collected as part of the scientific research.